Instructive Signals for Motor Learning

DESCRIPTION (provided by applicant): Motor learning is the process by which movements become smooth and accurate through practice. Motor learning is important during early childhood development, and continues throughout adulthood, because the neural circuits controlling our movements need to be recalibrated in response to changes in the brain or body due to injury, disease, or the normal aging process. Motor learning depends on a brain region called the cerebellum, and patients with cerebellar dysfunction have clumsy, uncoordinated movements. One of the two main inputs to the cerebellum is the climbing fiber input from the inferior olive in the brainstem. An influential theory of cerebellar function suggested that the climbing fibers carry the error signals that control motor learning. However, recent evidence suggests that motor learning can occur in the absence of instructive signals in the climbing fibers. Thus, there seems to be more than one way to implement motor learning in the brain. The goal of this project is to determine which aspects of motor learning are controlled by the activity of the climbing fibers, and which aspects of learning rely on other neural mechanisms. This question will be addressed by studying the eye movement responses to vestibular stimuli (i.e., the sensory signals encoding movements of the head) and their regulation by motor learning. Most, if not all, movements are guided by vestibular signals. The eye movement response to a vestibular stimulus is called the vestibulo-ocular reflex (VOR). This vestibular reflex functions to stabilize visual images on the retina, and is essential for maintaining good vision during movements of the body. Both the amplitude and the timing of the eye movements driven by the VOR can be adaptively modified by cerebellum-dependent learning, and thus the VOR serves as a model system for studying the neural mechanisms controlling movement amplitude and timing more generally.

Public health relevance
PUBLIC HEALTH RELEVANCE: An important characteristic of neural circuits is their plasticity, their ability to change with experience and to compensate when injury or disease damages the nervous system. This project studies the error signals that guide the changes in a neural circuit during learning. An improved understanding of this process will inform the development of more effective interventions for a broad range of neurological and psychiatric disorders. An important characteristic of neural circuits is their plasticity, their ability to change with experience and to compensate when injury or disease damages the nervous system. This project studies the error signals that guide the changes in a neural circuit during learning. An improved understanding of this process will inform the development of more effective interventions for a broad range of neurological and psychiatric disorders. __SpecificAimsTextDelimiter__ SPECIFIC AIMS What is the algorithm a neural circuit uses to learn? More specifically, for cerebellum-dependent motor learning, which neurons are monitoring the accuracy of movements, and how do they determine when the circuit controlling a movement needs to be modified? The question of how neural activity controls the induction of plasticity in vivo is one of the most central questions one can ask about the neural mechanisms of learning. For many decades, studies of cerebellum-dependent learning have focused on the role of the climbing fibers in carrying the neural instructive signals that control the induction of plasticity. However, our recent results (Ke et al, 2009) indicate that climbing fiber-independent plasticity mechanisms also contribute to cerebellum-dependent learning. With the new insight that cerebellum-dependent learning is not a unitary process, my lab is now undertaking a systematic research program to dissect cerebellum-dependent learning into its component parts, and identify the molecular, cellular, and electrophysiological underpinnings of each. The proposed experiments will significantly advance this broad goal and will bridge much of the molecular- genetic, electrophysiological and behavioral analyses we have done previously. The proposed experiments analyze the role of climbing fiber activity in the induction of different components of cerebellar learning, by combining the analytical power of oculomotor system with new, optogenetic approaches for precisely manipulating the activity of particular types of neurons within a circuit. We will first record the putative neural error signals in the climbing fibers during a battery of closely-related oculomotor learning tasks (Aim 1). We will then use optogenetic techniques to play back the climbing fiber responses recorded during learning to ask whether they can replace the sensory error signals that normally trigger learning (Aim 2). AIM 1. Record the putative instructive signals in the climbing fibers during a range of oculomotor learning paradigms in mice. We will record the climbing fiber responses during a set of visual-vestibular training stimuli that induce adaptive, learned changes in the amplitude (gain) and temporal properties (phase) of the vestibulo-ocular reflex (VOR). These will be the first recordings from cerebellar neurons during VOR learning in mice, and the first recordings from cerebellar neurons during VOR phase learning in any species. Moreover, the recording data we acquire in this Aim will be used to guide the parameters of optogenetic climbing fiber stimulation in Aim 2. AIM 2. Determine the extent to which direct, optogenetic activation of the climbing fibers can substitute for the sensory error signals that normally drive learning. To the extent that activity in the climbing fibers provides instructive signals guiding motor learning, direct activation of the climbing fibers should be able to replace the visual stimuli that are normally paired with a vestibular stimulus to induce motor learning in the VOR. In this Aim, we will determine which components of motor learning in the VOR (gain increases, gain decreases, phase leads, phase lags) can be induced by pairing vestibular stimuli in total darkness with direct, optogenetic activation of the climbing fibers. Our previous results suggest that these different aspects of VOR learning are supported by different plasticity mechanisms, therefore they may be differentially dependent on instructive signals carried by the climbing fibers. We will carefully analyze how the parameters of climbing fiber activation influence the induction of behavioral plasticity, to gain insight about the neural learning rules being implemented in vivo. These experiments harness the power of optogenetics and the oculomotor system to advance our understanding of learning at the circuit level and thus begin to bridge the gap that currently exists between our understanding of plasticity at the cellular-molecular and behavioral levels. The insights we gain by studying this well-defined experimental system should provide valuable guidance for studies of more complex neural circuits and behaviors.